Defining the function and mechanism of regulatory ribosomal ubiquitylation

PROJECT SUMMARY
Protein homeostasis (proteostasis) relies on the continual surveillance and removal of defective translation
products resulting from the relatively high error rates associated with mRNA translation. Proteostasis
dysfunction has been implicated in human aging-related pathologies, including many neurodegenerative
disorders, suggesting that molecular strategies to either limit the production of erroneous translation products
or elevate protein quality control capacity may provide therapeutic benefit. As such, characterizing cellular
mechanisms that regulate translation activity or ribosome-associated quality control function is needed to
enable molecular control over proteostasis under normal and stress conditions. We have discovered
conserved, site-specific, regulatory ribosomal ubiquitylation (RRub) events on individual 40S ribosomal
proteins that represent a new axis of translational control. Our objective is to determine the molecular
mechanisms by which RRub impacts ribosome-associated quality control and the integrated stress response
pathway. Toward this goal, we have identified the critical ubiquitin ligases and deubiquitylating enzymes that
mediate these RRub events. We have generated a unique and powerful set of genome-edited cell lines that
will enable molecular dissection of RRub and the cellular pathways which require RRub for proper function.
Our hypothesis is that manipulation of RRub machinery can be utilized to alter translation both during and
following acute proteotoxic stress. Furthermore, we hypothesize that cells with elevated translation activity
and/or elevated levels of damaged or cleaved mRNAs will require enhanced quality control activity for function
and survival. To probe these hypotheses, we will: (1) dissect ubiquitin-dependent and independent
mechanisms within the ribosome-associated quality control pathway; (2) determine physiologically-relevant
cellular conditions that require elevated RQC activity; and (3) characterize how RRub reshapes translation at
steady-state and during activation and recovery of the integrated stress response. Research outcomes
achieved by the proposed studies will mechanistically determine how terminally stalled ribosomes are sensed
and resolved via the RQC pathway. We will also define how RRub alters stress response pathways through
regulation of ribosome abundance or translation activity. Several ribosomal proteins and translation-associated
factors are regulatory ubiquitylation targets which suggests that our research strategy can be broadly applied
to other targets to enable protein biogenesis control at multiple steps. Successful completion of the proposed
research will provide substantial progress toward our long-term goal of combating aging-associated human
pathology through the development of molecular strategies to modify cellular responses to chronic proteotoxic
stress and improve cellular fitness following proteostasis insults.

Public health relevance
PROJECT NARRATIVE The prevalence of neurological disorders has doubled in the past 20 years and continues to escalate such that it is estimated that over 13.8 million people in the US will be afflicted with a neurological disorder by 2050. Defects in the cellular pathways that limit the abundance or facilitate the removal of potentially toxic proteins have been linked to increased neurological dysfunction and decreased overall longevity. Research within this proposal focuses on combatting aging-associated disorders through the targeted manipulation of factors that can reduce the toxicity of defective proteins by either limiting their production or enhancing their destruction.